A daily diary examination of the influence of intersectional stigma on blood pressure

Hypertension is the most important modifiable risk factor for cardiovascular disease (CVD), the leading cause
of death and disability in adults worldwide. Stigmatized populations, such as people of color and sexual
minority (e.g., gay/lesbian, bisexual) adults, have a higher prevalence of hypertension that is largely attributed
to greater exposure to stigma; a fundamental cause of health disparities. However, prior research on the effects
of stigma on blood pressure (BP) has primarily focused on enacted stigma (i.e., personally experienced
discrimination) to the exclusion of other forms of stigma, such as anticipated (i.e., expectation of encountering
discrimination) and vicarious (i.e., hearing/witnessing people like you being the target of discrimination)
stigma. Most research in this area has focused on the impact of stigma on BP due to a single stigmatized
identity. This current approach ignores intersectional stigma (i.e., stigma that is not attributed to a specific
identity), which obscures the experiences of groups that face stigma due to multiple stigmatized identities.
Given these limitations, we posit that researchers have previously underestimated the impact of stigma on BP.
We have compelling pilot data showing that, independent of enacted stigma, greater reports of daily
intersectional anticipated and vicarious stigma are associated with higher home systolic BP (SBP; a stronger
predictor of future CVD events than in-office SBP) among adults. The goal of this 1-week daily diary study is to
estimate the influence of intersectional anticipated and vicarious stigma on home BP. We will conduct the first
study to robustly examine mechanisms linking daily and chronic anticipated and vicarious stigma with BP in
individuals’ real-world environments. We will recruit a diverse sample of 400 adults (ages 18-64) without
diagnosed hypertension or CVD. Participants will complete a structured interview followed by 1 week of: (1)
twice-daily structured electronic diaries that will assess daily anticipated, vicarious, and enacted stigma, (2)
collection of saliva samples to assess salivary stress biomarkers, (3) continuous wrist-worn actigraphy, and (4)
twice-daily home BP monitoring. Our specific aims are to: (1) Determine the influence of intersectional
anticipated and vicarious stigma on mean home SBP and mediators of these associations (e.g., salivary cortisol,
anxiety) and (2) Examine differences in intersectional anticipated and vicarious stigma and mean home SBP
across stigmatized identities (e.g., ethnoracial, sexual identity) and the intersections between them. We will
also explore moderators (e.g., social support, identity centrality) of the influence of intersectional anticipated
and vicarious stigma on mean home SBP. This study will provide the first evidence of mechanisms by which
anticipated and vicarious stigma influence BP. If we find that anticipated and/or vicarious stigma influence
BP—even in the absence of enacted stigma—it will shift how we think about the design of interventions for CVD
risk reduction. This study is a critical step for identifying mechanistic targets for future interventions and
policies to reduce the adverse effects of anticipated and vicarious stigma on cardiovascular health.

Public health relevance
PROJECT NARRATIVE Stigma is an important social determinant of health among stigmatized adults, yet previous research has not comprehensively tested the impact of multiple forms of stigma on blood pressure, a strong predictor of future cardiovascular disease and mortality. Findings from this study will provide the best evidence to date on mechanisms by which anticipated and vicarious stigma influence blood pressure. This study is a critical step for identifying mechanistic targets for future interventions and policies to reduce the adverse effects of stigma on cardiovascular disease risk in stigmatized adults.